A Multicenter Randomized Clinical Trial Comparing Two Human Milk Volumes to Optimize Growth and Gut Health in Infants Born Very Preterm

PROJECT SUMMARY
The nutritional management of very preterm infants (27 to 31 weeks of gestation) is critical due to their
increased risk of faltering growth and adverse metabolic outcomes. Current recommendations for human milk
intake range widely from 140 to 200 ml/kg/day. This variability reflects a lack of consensus on the optimal
volume to support growth while minimizing risks like obesity. Unlike preterm formula, human milk is believed to
protect against metabolic diseases due to its unique nutritive and non-nutritive components.
Previous randomized clinical trials have not examined the effects of two enteral fluids intakes on very preterm
infants fed human milk exclusively. This project aims to address this knowledge gap by exploring how different
volumes of human milk affect fat-free mass (FFM) and body fat accumulation, essential for the development of
very preterm infants.
The primary objectives of this multicenter, unmasked, randomized clinical trial are 1) to assess growth and
metabolic outcomes at term-age equivalent of very preterm infants receiving higher volumes of human milk,
and 2) to characterize the gut microbiome assembly patterns in response to these human milk volumes. Our
central hypothesis is that providing human milk volumes of 180 to 200 ml/kg/day during the first weeks after
birth will improve FFM accretion and reduce the risk of adverse metabolic outcomes at term-age equivalent in
very preterm infants. To test this hypothesis, we will randomize 486 very preterm infants into two groups: one
receiving 180 to 200 ml/kg/day and the other 140 to 160 ml/kg/day. We will measure daily human milk volumes
and weekly macronutrient content of human milk diets. We will assess FFM accretion at study entry, study day
14, study completion, and term-age equivalent or discharge. We will also examine how human milk volumes
influence the gut microbiome through shotgun metagenome sequencing of serial fecal samples collected
during the trial and establish a correlation between specific gut microbiome compositions and untargeted
serum metabolomics.
This trial aims to generate high-quality clinical and translational data on the interactions between early life
diets, the gut microbiome, and growth in very preterm infants. It aligns with the 2020-2030 NIH Nutrition
Research Strategic Plan by determining the health benefits of exclusive dietary patterns, investigating host-
microbiome interactions, and reducing the burden of disease in clinical settings. If successful, this patient-
oriented, comparative-effectiveness trial will provide critical insights into optimal nutrition strategies for very
preterm infants, potentially transforming clinical practices worldwide and enhancing the development and long-
term health of this vulnerable population.

Public health relevance
PROJECT NARRATIVE This project explores how different amounts of human milk affect the growth and gut health of very preterm infants. By identifying optimal milk intake levels, we aim to improve their development and reduce risks of future health problems, providing critical insights for neonatal care.